Evaluating Maternal and Neonatal Pharmacokinetics of Cystic Fibrosis Transmembrane Conductance Regulator (CFTR) Modulators - The ELECTRA Pregnancy Study

ABSTRACT
Cystic fibrosis (CF) is a devastating multi-organ system disease that results in lifelong morbidity and
early mortality. Cystic Fibrosis Transmembrane Conductance Regulator (CFTR) modulators
(elexacaftor/tezacaftor/ivacaftor) have revolutionized CF patient care, restoring normal function to people with
CF (pwCF) who respond. Their use also tripled pregnancy rates in pwCF, a population where subfertility and
maternal complications exist at a significantly higher rate. Pregnant women with CF have an increased risk of
infection, requiring prolonged hospitalizations for intravenous antibiotics and other complications, including
pulmonary decline. Consequently, they are advised to continue CFTR modulator therapy to prevent maternal
deterioration, despite the lack of scientific evidence demonstrating their optimal dosing in pregnancy. As such,
it is critical to define the pharmacokinetics of CFTR modulators in pregnancy and postpartum, including effects
on the developing fetus, the infant, and breastmilk composition.
Former NIH Director, Dr. Francis Collins, highlighted critical knowledge gaps in the pharmacology of
modulator drugs, and in 2022 the NIH reaffirmed these gaps to include optimal dosing, pharmacology, and use
in pregnancy and lactation. Our research group’s ongoing studies with the triple combination (TC) therapy
(elexacaftor/tezacaftor/ivacaftor) in the adult CF population reveal substantial inter-individual variation in the
concentrations of these compounds that can affect response. Previous attempts to define the
pharmacokinetics of CFTR modulators in postpartum patients have been unsuccessful due to difficulties with
recruitment and retention. To address this challenge, we have identified seven geographically diverse clinical
research centers across the U.S. with exceptional recruitment and retention records in both the Cystic Fibrosis
Foundation/Therapeutic Development Network and the NIH/NICHD Maternal-Fetal Medicine Units Network.
Led by a team of Cystic Fibrosis and Maternal-Fetal Medicine investigators, we will enroll 30 pregnant, first-
trimester, patients on TC to investigate the following aims: 1) To determine the pharmacokinetics of each
compound in CFTR modulator therapy, including active metabolites, in pregnant individuals in each trimester
and postpartum, and 2) To evaluate the wash-out pharmacokinetics of each compound in CFTR modulator
therapy, including active metabolites, from newborns of mothers taking TC. The ELECTRA Pregnancy Study is
poised to generate rigorous CFTR Modulator pharmacokinetic data to inform optimal CFTR Modulator dosing
to improve outcomes for pregnant patients with cystic fibrosis and their infants.

Public health relevance
PROJECT NARRATIVE Cystic Fibrosis Transmembrane Conductance Regulator (CFTR) modulators have revolutionized the care of people with cystic fibrosis and tripled pregnancy rates. When patients with cystic fibrosis become pregnant, physicians advise them to continue CFTR Modulator medication, even though there are not adequate studies demonstrating the optimal dosing in pregnancy, how it affects the developing fetus, or composition in breastmilk; therefore, pharmacokinetics data are urgently needed to optimize CFTR Modulator dosing for pregnant patients with CF and their developing baby. We propose ELECTRA, a multi-center CFTR Modulator pharmacokinetics study made possible through collaboration between Cystic Fibrosis and Maternal-Fetal Medicine Investigators at 7 sites across the United States to define CFTR therapeutics during pregnancy.